Dose Linear Energy Transfer Volume Histogram and Dosimetric Seed Spot Analysis in Spot Scanning Proton Therapy

PROJECT SUMMARY/ABSTRACT
Radiation therapy may induce severe adverse events (AEs), and result in significant detriment to patients’ quality
of life, especially in head and neck, such as brain necrosis (BN), osteoradionecrosis (ORN), etc. It is important
to develop safer radiation therapy delivery models to minimize the risks of AEs. Spot scanning proton therapy
(SSPT) provides such an opportunity due to its unique physics characteristics, i.e., Bragg peak. But it also
introduces additional complexities since proton deposits most of the energy within a short distance, resulting in
high linear energy transfer (LET) compared to traditional photon therapy. Therefore, its relative biologically
effective (RBE) dose may vary significantly even for the same delivered physical dose. However, clinical use of
LET is limited because of the uncertainties and discrepancies in RBE modelling and calculation. Thus, current
SSPT plan evaluation exclusively relies on physical dose and ignores critical LET information. In this project, we
propose a novel tool of dose-LET volume histogram (DLVH) to visualize dose, LET, and structure volume in one
3D surface plot. While avoiding parameters with large uncertainties in RBE modelling, we will correlate AEs with
well-defined quantities of dose/LET to establish dose-LET volume constraints (DLVCs) at the organ level.
The follow-up medical images (CT, PET, and MRI etc.) showed that only a small portion of regions (seed spots)
at the AE sites originated from the synergistic effects of high dose and LET. These seed spots then expand to
nearby voxels with low dose/LET due to biological processes to form AE sites identified later in the follow-up
images. The inclusion of these voxels with low dose/LET will introduce lots of “noise” in the data analysis. Thus,
it is important to filter these “noise” from the true “signals” if we want to understand the dose-LET effects in AE
initialization. We propose a novel voxel-based method, dosimetric seed spot analysis, for studying the dose-LET
effects upon AE initialization at the voxel level. Seed spot analysis is akin to the patch-based methods in medical
image analysis and identifies seed spots. Empirical AE models will be developed via dosimetric seed spot
analysis with critical voxels selected by the population-based DLVC. The inter-patient variation will be considered
by the two-level mixed effect logistic regression model. The normal tissue complication probability models will
be established based on DLVCs and be applied in clinical practice for plan evaluation, and we will then develop
DLVH-based treatment planning using DLVC in SSPT to prospectively minimize the possible incidence of AEs.
The proposed project will be carried out by experts from Mayo Clinic, MD Anderson, New York Proton
Center/Memorial Sloan Kettering, and the University of Georgia. Our project will fill a critical technology void in
SSPT and is one of the largest in-vivo outcomes-driven studies to investigate the impact of LET. The success of
this study will become a major advancement to the current standard of care of SSPT plan evaluation and
optimization using physical dose alone, leading to precision radiation therapy and improved clinical outcomes.

Public health relevance
PROJECT NARRATIVE The overarching goal of this proposal is to enable clinical use of linear-energy-transfer (LET) in spot scanning proton therapy (SSPT) for head and neck (H&N) cancer based on patient outcomes with adverse event (AE) sites contoured using following-up medical images (CT, PET, and MR etc.) to minimize the risks of AEs. We will develop dose-LET volume histogram (DLVH) based plan evaluation and treatment planning methods in SSPT for H&N cancer management using patient outcomes and following-up medical imaging analysis-derived dose-LET volume constraints (DLVCs) and develop the empirical AE models using domestic seed spot analysis based on medical imaging analysis. The success of this study will open new avenues in SSPT plan evaluation and treatment planning, leading to precision radiation therapy and improved clinical outcomes.